Protocol Review and Monitoring System

PROJECT SUMMARY: PROTOCOL REVIEW AND MONITORING SYSTEM
The Buffett Cancer Center (BCC) has established a process by which proposed BCC clinical and population
science research protocols undergo internal peer review for scientific merit and prioritization prior to University
of Nebraska Medical Center (UNMC) Institutional Review Board approval. The BCC SRC is a multidisciplinary
committee charged with overseeing the scientific aspects of cancer-related research involving human subjects
conducted by members of the UNMC faculty and students, and BCC Members. Cancer prevention studies,
screening trials, behavioral studies, quality of life / survivorship studies, and interventional trials that rely on
collection of patient-reported outcomes are reviewed by the SRC. The BCC SRC has the authority to approve,
require modifications, or disapprove research activities that fall within its jurisdiction. The SRC confirms the
scientific validity of the proposed study, and assesses the feasibility of the study relative to the availability of
human subjects and ongoing protocols based on enrollments from that same or patient and/or subject
population. The BCC SRC review also assures that the data and safety monitoring plan for the proposed
clinical trial is appropriate and in accordance with regulations, and provides feedback and recommendations to
the investigator, to enhance the scientific merit and/or the logistics of the planned study. Initial review includes
two stages, beginning with preliminary review and approval by the Disease Focused Teams (DFTs) followed
by the SRC review. National, Externally Peer Reviewed and Multi-Institutional studies with an approved NCI
Designated or Comprehensive Center as the lead site, received expedited review, which focuses on priority
and feasibility. The BCC SRC members are selected to represent the broad spectrum of oncology research.
The BCC SRC has broad expertise with representation from Medical, Surgical, Pediatric and Radiation
Oncology, Pharmacology, Pathology, Nursing and Biostatistics. The Committee also has broad expertise in
hematological malignancies and solid tumors, as well as in clinical research in supportive care and symptom
management. Any Cancer Center member with expertise specific to a particular protocol may also be asked to
serve as an at-large or ad-hoc reviewer based on their unique qualifications or when expertise is not available
from SRC members.